Impact of Climate Change on Life Expectancy in a Multiethnic Population

ABSTRACT
Climate change is a growing public health priority as extreme heat, wildfires, and other natural disasters have
led to acute effects on morbidity and mortality; yet, the long-term consequences of extreme heat and wildfires
have been sparsely studied. This is due in part to the paucity of studies with longitudinal information on
individual- and neighborhood-level factors and fine-scale climate and wildfire data. There is an urgent need to
investigate the long-term consequences of extreme heat and wildfires in well-designed studies that include a
comprehensive assessment of these exposures and their independent and joint effects on life expectancy,
coupled with a critical evaluation of possible mediators (air pollution) and moderators (socioeconomic status,
demographics, comorbidities, health behaviors, neighborhood environments, and geography). Furthermore,
the biological processes by which climate change affects mortality are not well understood. While evidence of
the impact of air pollution on DNA methylation as a measure of epigenetic regulation is accumulating, studies
of extreme heat and DNA methylation are sparse. Elucidation of the underlying pathways and the identification
of interventions for high-risk groups are needed. To address these gaps, we will conduct a rigorous
investigation of the impacts of extreme heat and wildfire smoke on adult life expectancy, leveraging the unique
epidemiological resources of the Multiethnic Cohort Study, a large population-based study that includes
112,000 adult men and women from California, who were ages 45-75 at enrollment in 1993-1996 and currently
ages 72-103 with strong representation of diverse racial/ethnic and socioeconomic groups. Specifically, we will
generate and characterize extreme heat and wildfire smoke for California Multiethnic Cohort participants
spanning a 24-year period (Aim 1); assess the impacts of long-term exposures of extreme heat and wildfire
smoke on life expectancy (Aim 2); and DNA methylation and epigenetic age (Aim 3). The strengths of this
proposal include: 1) the use of state-of-the-art exposure assessment methods to characterize extreme heat,
wildfire smoke, and important criteria air pollutants; 2) a large population-based sample with detailed individual-
and neighborhood-level data and sufficient power to detect modest effects that are broadly generalizable to
similar sex, racial/ethnic, and socioeconomic groups in the US; 3) the assessment of the role of biological
pathways (DNA methylation) by which extreme heat and wildfire smoke may operate; and 4) a thorough
investigation of effect modification by a variety of factors including modifiable neighborhood environments as
well as the mediation of effects by air pollution. Findings from this proposal will expand our understanding of
the contribution of long-term extreme heat and wildfire smoke on life expectancy. This knowledge has
translational relevance in providing empirical evidence for policy makers and implementation scientists to
develop strategic interventions and response plans to combat the health effects of extreme heat and wildfire
smoke.

Public health relevance
PROJECT NARRATIVE We will examine the associations of extreme heat and wildfire smoke exposures in relation to life expectancy and DNA methylation. In particular, we will evaluate whether air pollution mediates the association between extreme heat and mortality as well as characterize differences in associations across vulnerable populations. The proposed study will be conducted among 112,000 participants from the California component of the Multiethnic Cohort Study.